Qualification of Composite Quantitative Imaging Biomarkers for Diagnostic Enrichment in Nonalcoholic Steatohepatitis (NASH) Clinical Trials (DDTBMQ000112)

SUMMARY
The long-term goals of this U01 grant proposal are to reduce the number of liver biopsies required to achieve
target enrollment in nonalcoholic steatohepatitis (NASH) drug development trials by rigorously qualifying
composite quantitative imaging biomarkers through the FDA CDER Biomarker Qualification Program; repeat
this process for other contexts of use related to NASH drug development trials; and monitor and assess the
use of FDA-qualified quantitative imaging biomarkers in NASH drug development trials to help further refine
the process by which these biomarkers are qualified. Our immediate goal is to prepare, submit, and obtain
approval for the Qualification Plan being proposed here for the composite quantitative imaging biomarkers
proposed in our Letter of Intent. This work is leveraged by ongoing development of metrics of conformance
from the Quantitative Imaging Biomarkers Alliance (QIBA), pending results from the $15M NIMBLE Study
being conducted by the Foundation of the NIH and funded by numerous pharmaceutical industry partners, and
FDA guidance on contexts of use in medical research. The central hypothesis of this proposal is that prior
research and pending NIMBLE Study results on the quantitative imaging biomarkers described in our
Letter of Intent are sufficiently mature for purposes of diagnostic enrichment to merit preparation of a
Qualification Plan. We are encouraged in PAR-21-178 to focus our grant proposal on filling gaps for the
Qualification Plan submission. Hence, we chose four Primary Aims to address the fourteen questions
provided to us by FDA concerning biomarker descriptions, and context-of-use-related analytical, clinical, and
statistical considerations. Our milestone of success for each of our four Primary Aims is acceptance by FDA
of our responses to their questions. Potential impact of this project is high because it addresses a critical
barrier to progress in NASH drug development. Successful completion of this project will help change the
current paradigm of diagnostic enrichment in NASH drug development trials, and will accelerate the
development of safe and effective medical products for the patients who need them the most. If the aims of this
grant proposal are met, preparation of a Full Qualification Package will be justified. If that package is also
accepted, our methodology to secure biomarker approval may expedite qualification of other biomarkers for
other contexts of use including early detection, diagnosis, staging, monitoring, and treatment response for
NASH, thereby facilitating screening, enrollment, and execution of clinical trials to accelerate drug discovery.

Public health relevance
PROJECT NARRATIVE As part of the FDA CDER Biomarker Qualification Program, the goal of this U01 grant is to prepare, and to obtain approval of a Qualification Plan for composite quantitative imaging biomarkers intended to facilitate diagnostic enrichment in nonalcoholic steatohepatitis (NASH) drug development trials. If the aims of this grant are met, preparation of a Full Qualification Package will be justified. Acceptance of that package and final qualification of the proposed composite biomarkers by FDA for purposes of diagnostic enrichment in NASH drug development trials will reduce the number of liver biopsies required in those trials, thereby reducing study costs, reducing burden to study participants, and facilitating screening, enrollment, and execution of those trials to accelerate drug discovery.